PHARMACOKINETICS OF A 12-HOUR TRANSDERMAL DELIVERY OF 17-BETA ESTRADIOL

This descriptive study is designed to characterize the pharmacokinetics of an acute 12-hour administration of 17-beta-estradiol.